Research Education Component

PROJECT SUMMARY- RESEARCH EDUCATION COMPONENT
The Research Education Component (REC) will develop and implement a robust educational program to
increase access to highly inclusive training for diverse Alzheimer’s Disease and Related Dementias (ADRD)
rising researchers and research workforce. The REC will be building on the University of New Mexico (UNM)’s
strengths as a minority-serving Institution (MSI), as well as the only Research University in New Mexico to
advance innovative ADRD research education that is scientifically and culturally groundbreaking. Consistent with
the overall theme of the New Mexico Alzheimer’s Disease Research Center (NM ADRC), the REC will develop,
upscale, deliver, and evaluate research educational activities to meet ADRD biomedical, behavioral, and clinical
research needs, with a focus on research education on vascular and inflammatory contributions to Alzheimer's
and cerebrovascular diseases in underrepresented groups in New Mexico. The REC’s long-term goal is to
increase the capacity of the next generation of leading ADRD scientists to champion disruptive and
transformative research that would meet the needs of diverse patients and caregivers nationally, and in the Rocky
Mountains region. The REC aims to: enhance ADRD research by training the next generation of ADRD
diverse scientific leaders (Aim 1); increase access to ADRD research careers by developing and
implementing a plan for a dynamic pipeline that follows a recruitment plan to enhance diversity (Aim 2);
and create a dynamic educational environment that supports multi-disciplinary, inclusive science
research skills of researchers and research workforce (Aim 3). Our plan is to provide mutually beneficial
training opportunities to many trainees across different platforms. The REC is ideally poised to facilitate such
interactions, providing communication, oversight, and coordination that can boost the interactive nature of our
center. By applying principles of and culture-centeredness, we will broaden the scope and impact of ADRD
research and prepare a new generation of ADRD researchers who will design and carry out disruptive,
translational studies and bring their newly acquired skills to serve diverse patients. This ADRC will play an
important role in solidifying a culturally informed infrastructure for basic and clinical ADRD scientific mentoring
of promising trainees who are representative of NM communities. In addition to the development of new leaders
devoted to ADRD research to improve prevention, diagnosis and treatment and eliminate health inequities in
ADRD, the NM ADRC will contribute to the field by developing and disseminating novel research education
training models, and in particular those focusing on understanding vascular and inflammatory contributions to
Alzheimer's and cerebrovascular diseases, culture-centered mentoring, and engagement of minoritized groups
in research and clinical trials within the ADRC national network and beyond.